User Training and Outreach

The two main goals of the user training and outreach component are: (1) provide user training to prepare
biomedical researchers to apply NE-CAT technology to their research, and (2) engage in outreach activities
to inform the scientific community about the technical capabilities of NE-CAT, promote and enable broader
use of NE-CAT technologies, and actively recruit new user research projects to NE-CAT. User training
includes online manuals and videos, which are regularly updated, one-on-one, in person training for on-site
users, and videoconference-based training for remote users. We also provide enhanced training on all
aspects of macromolecular crystallography from sample preparation to structure determination and
refinement. We will develop a new system for tracking the training status of each user, enabling support
staff to tailor their efforts more effectively. Our training activities extend to the larger user community
through annual workshops. We will expand our training by offering a class on practical macromolecular
crystallography to both the NE-CAT community and outside groups. NE-CAT maintains a website that is
largely targeted to past and present users. We will expand the website to contain more information of
interest to potential new users. NE-CAT freely distributes software such as RAPD, NE-CAT’s automated
data collection and analysis software, and all hardware designs, many of which have been adopted by other
APS beamlines. We will increase the diversity of our user community through a combination of outreach to
new primary investigators and enhanced retention efforts for current primary investigators and postdoctoral
scientists.